Behavioral Oncology Education & Career Development

PROJECT SUMMARY
This proposal is a competitive renewal application submitted in response to PA-18-403
(Institutional Research Training Grant). In accordance with the program announcement,
we seek continued funding for the Moffitt Cancer Center Post-Doctoral Training Program
in Behavioral Oncology, originally funded under the R25T mechanism in 2003, that trains
postdoctoral fellows in highly interdisciplinary and collaborative cancer research settings.
Specific aims are to: 1) continue the development and refinement of a curriculum-
dependent post-doctoral training program in behavioral oncology research that draws
upon the faculty and resources of the Moffitt Cancer Center and the University of South
Florida; 2) recruit a diverse group of promising trainees who are committed to careers as
researchers in translational behavioral oncology; and 3) provide trainees with
knowledge, skills, opportunities, and mentoring needed to become leading scientists in
translational behavioral oncology. The training program builds on extensive and
productive collaborations among researchers with diverse backgrounds in behavioral
science, population science, health communications, nursing, and medicine. These
researchers are all faculty at the University of South Florida and members of the Division
of Population Sciences, primarily the Health Outcomes and Behavior Program, at Moffitt
Cancer Center. A key feature of this program has been the development and refinement
of a specialized curriculum in behavioral oncology not otherwise available at our
institution that is clearly linked to the program's training goals and objectives. As
described in the application, this specialized training consists of a required core
curriculum for both first-year and second-year trainees and an elective curriculum,
designed to provide individualized training, that is selected by each trainee in
consultation with his/her training committee. Since the last competitive renewal, the
program has continued to be successful in attracting a talented and diverse pool of
applicants, recruiting the best applicants from this pool, and providing the trainees
recruited with the skills, experiences, and mentoring necessary for becoming successful
independent investigators in the field of behavioral oncology.

Public health relevance
PROJECT NARRATIVE This application seeks continued funding for a program that provides post-doctoral training in behavioral oncology research. Since 2003, the program has been successful in attracting a talented and diverse pool of applicants, recruiting the best applicants from this pool, and providing the trainees recruited with the skills, experiences, and mentoring necessary for becoming successful leading investigators in the field of translational behavioral oncology.